The Simian Collective

Project Summary.
This application is a request for funds to support a conference entitled the ‘Simian Collective’ that highlights
nonhuman primate neuroscience research in the United States, its unique role as a translational model of
human neuropsychiatric disorders and seeks to build crucial community effort to address the key challenges
facing the field in the 21st Century. The foundational tenet of the Simian Collective is that maximizing the
impact of primate neuroscience research in the modern era necessitates complementary goals of Science,
Ethics, Education and Advocacy. Owing to the shared functional organization of the primate brain, our simian
cousins are uniquely powerful models to elucidate many facets of human brain function in both health and
disease. This cutting-edge research must continue to grow and receive renewed investments to prosper. The
meeting will also emphasize that phylogenetic advantages of using animal with so many shared characteristics
for investigative research must also be balanced by the crucial neuroethical considerations that inevitably
emerge because of these similarities. Furthermore, the Simian Collective will also emphasize the responsibility
of the field to educate our scientific colleagues and general population about the unique importance of primate
research and to advocate for its significance. The program of the meeting has been designed to emphasize
the complementary relationship between these core tenets, and to build a community initiative to build and
promote primate neuroscience research in the coming years.

Public health relevance
Project Narrative. The principal goal of the Simian Collective is to highlight the significance of primates in neuroscience research, including their unique significance as translational models of human neuropsychiatric diseases and disorders. The meeting is organized to emphasize that realizing the maximal impact of primate models in the 21st Century necessitates complementing cutting- edge research with neuroethical considerations, as well as educating the broader scientific and general communities about the importance of primate neuroscience research. This meeting will provide an important forum in which to build the community involvement needed to make these important steps in the next chapter of the field.